Unveiling Novel Mechanisms Governing Organelle-Dependent Quality Control of Tail-Anchored Membrane Proteins

Project Summary/Abstract:
Membrane proteins are critical for organelle identity and function. Among these, tail-anchored (TA)
proteins represent a special class of membrane proteins that are post-translationally inserted into their respective
membrane via a single C-terminal transmembrane (TM) domain. TA proteins are prone to mislocalization, which
can disrupt cellular function and initiate proteostatic collapse, a hallmark of age-related disease. While initial TA
protein studies focused on yeast, mammalian systems represent a richer diversity of TA proteins and, in tandem,
regulatory mechanisms. In this proposal, I will explore how mammalian TA quality control systems function, using
the TA protein BNIP3 as a model. BNIP3 dually localizes to the ER membrane and outer mitochondrial
membrane (OMM) and has been broadly implicated in organismal health span and aging. BNIP3 function and
stability are regulated by the homodimerization of its transmembrane domain. By generating BNIP3 variants that
localize exclusively to either the ER or OMM, this project aims to dissect 1) the specific signals used to identify
orphan TA proteins, 2) the cellular machinery that recognizes them, and 3) how this dictates BNIP3 fate across
organelles. The project will be pursued through two main objectives: In Aim 1, I will utilize a fluorescent reporter
for ER-localized BNIP3 to pinpoint the critical signals within BNIP3 necessary for its recognition and proteasomal
processing from the ER membrane. In addition, I will perform an unbiased genome wide CRISPR knockout
screen to identify the cellular factors mediating TA quality control at the ER. In Aim 2, I will utilize a fluorescent
reporter for OMM-localized BNIP3 to identify the signals within BNIP3 necessary for its turnover from the OMM,
as well as investigate the factors mediating TA quality control from the OMM, parallel to the approaches used in
Aim 1. This research promises to reveal the sophisticated mechanisms cells use to control the quality of TA
proteins like BNIP3, potentially highlighting novel ways in which the ER and mitochondria maintain proteostasis
through additional coordination. The findings from this work could subsequently open new avenues for
understanding mechanisms of age-associated proteostatic collapse.

Public health relevance
Project Narrative: Multiple quality control systems regulating tail-anchored (TA) membrane protein turnover have been identified in yeast. Mammalian systems however, express a larger repertoire of TA membrane proteins, and thus holds the potential to uncover an expanded ensemble of quality control factors. These findings could provide critical insights into protein homeostasis in aging as well as identify potential therapeutic targets in aging related diseases.